Functional Contributions of the Noncoding Genome in Atherosclerosis Risk Factors

PROJECT SUMMARY/ABSTRACT
This application describes a five-year plan for my career development to define the contributions of mouse and
human noncoding RNAs in cardiometabolic disorders. Sex differences are well-known in cardiometabolic
diseases including atherosclerosis. There are significant numbers of long noncoding RNAs (lncRNAs) that have
been implicated in executing functions in a highly context-specific manner, but their role in cardiovascular disease
remains a work in progress. A major limitation to appreciating the significance of lncRNAs between sexes is the
inability to test their function in vivo and having logical paradigms that prioritize lncRNA discovery. Thus, the
overarching scientific goal of this application is to examine the contribution of long noncoding RNAs in hepatic
lipid metabolism and their potential implications for cardiovascular and metabolic diseases. Leveraging an
ambitious in vivo screen, I have prioritized and focused on one lncRNA, Xtendr, that shows lipid sensitive and
highly sexually dimorphic effects. My preliminary data suggest that activating this lncRNA affects liver lipid
content using the liver specific CRISPR modulation mice. Capitalizing on my preliminary data and the cutting-
edge CRISPR activation and inhibition mouse models, I will test the influence and mechanism of Xtendr on
hepatic lipid homeostasis and sex-specific hepatic traits (Aim 1). In Aim 2, I will capitalize on an advanced
humanized liver mouse model that will be applied to interrogate the functional conservation of mouse lncRNAs
with their syntenic human orthologs. Collectively, this project will reveal the importance of uncharacterized
lncRNAs in sex dimorphic hepatic lipid metabolism within an in vivo system and uncover the challenging question
about the complex relationships between sequence, synteny, and functional conservation.

Public health relevance
PROJECT NARRATIVE Long noncoding RNAs are newly identified biologic mediators that have been shown to be important in health and disease. However, their roles in maintaining lipid homeostasis are less well defined. Through investigating a sex-specific lncRNA using unique mouse models, our work will provide new insights into the physiologic roles of sex-dimorphic lncRNAs and identify conserved human orthologs for new targets in lipid regulation.